Microbial mediation of lipid absorption in Drosophila

PROJECT SUMMARY
Since the industrial revolution, western diets have undergone significant transformation. These changes have
been associated with increased rates of metabolic disease. Changes in gut microbiota have been linked to
increased rates of these diseases, both in humans and mammalian models. However, the mechanism that
links the composition of the microbiome to onset of these metabolic diseases is unclear. One proposed
mechanism is the increase in lipid absorption observed both in fish and mammalian models, which has been
linked to the presence of specific bacterial species. However, a mechanism remains elusive. This proposal
aims to study the question of how the microbiome influences lipid absorption in the fruit fly Drosophila
melanogaster. Drosophila was selected for this project because of its small, tractable microbiome, relevance to
human gut biology, and the existence of a powerful library of existing genetic tools, such as RNAi,
overexpression and fluorescent protein lines. Using a combination of high-pressure liquid chromatography, and
fluorescent microscopy, I have preliminarily shown that the microbiome of Drosophila melanogaster increases
lipid absorption of the fluorescent fatty acid analog BODIPY-C12. In this proposal, I plan to verify this
phenotype and establish causative microbes and timing of lipid absorption (Aim 1),and investigate the
mechanism of this increase in lipid absorption by conducting a small RNAi screen on host genes thought to be
involved in lipid absorption, specifically focusing on the hypothesis that microbial-mediated pH drives changes
in the activity of these genes (Aim 2). Successful completion of the proposed aims will strengthen the link
between microbial colonization and increased lipid absorption observed previously in vertebrates (I), discover
genes important for lipid absorption in Drosophila (II), and establish Drosophila as tractable model for
understanding lipid absorption (III).

Public health relevance
PROJECT NARRATIVE Absorption of lipids from dietary sources is a key function of animal digestive systems and has been shown to be mediated by the gut microbiome through a yet unknown mechanism. This proposal will examine how specific bacterial species alter lipid absorption by using drosophila genetics, lipid chromatography, and microscopy with a specific focus on the drosophila foregut. This study will aid in our understanding of how lipid absorption occurs in animals and identify potential probiotic treatments for metabolic diseases.